Neural Engineering Training Program (NETP)

Neural Engineering Training Program (NETP)
NETP will train future translational scientists, engineers and clinicians to create innovative and clinically
relevant treatments for neurological disorders, by providing unique curriculum and training opportunities
for pre-doctoral students. Current treatments provide significant benefits to patients, but are in some ways
inadequate because they cannot reliably detect events (e.g. epilepsy), do not provide sensory information
at adequate resolution (visual prostheses), obtain low rate and inconsistent information (brain-machine
and peripheral nerve interfaces), or have significant side-effects (deep brain stimulation). To improve
these therapies, the field of neural engineering faces challenges related to acquiring and understanding
large amounts of data from the brain and peripheral nervous system. Clinical neural prostheses will also
require the ability to control neural circuits at high spatial and temporal resolution. Training the next
generation of leaders in Neural Engineering will accelerate the development of solutions to these
problems, but requires interdisciplinary training that not only teaches fundamental concepts but also
exposes trainees to clinical practice to inform and motivate research questions towards translational
goals. NETP will support four PhD candidates each year. NETP offers a rich, diverse curriculum as well
as a wide-range of activities to promote interactions amongst mentors and trainees. Key aspects of NETP
include co-mentoring of students by clinician-scientists, curriculum covering engineering, medical, and
scientific aspects of neural engineering, an annual statistics workshop to reinforce rigorous experimental
design and data analysis, medical seminars for engineering/basic science graduate students, specific
training in translational research, and a student run annual research symposium. The environment for
the NETP is world-class. Participating faculty leaders have expertise in neural prostheses, brain-machine
interfaces, neural signal processing, neuromodulation, computational modeling, biomaterials,
neuroscience, and bioelectronics medicine as well as medical school faculty in neurosurgery, urology,
neurology, ophthalmology, and anesthesiology. Importantly, the participating faculty include several
practicing clinicians who also serve as primary mentors for PhD students. State-of-the-art facilities include
the North Campus Research Center, Lurie nanofabrication facility, the Michigan vector core, and the
Material Characterization Center. The institutional environment is outstanding. Michigan has highly rated
engineering and medical schools with high quality research throughout the university, and is committed
to providing high quality graduate training.

Public health relevance
The Neural Engineering Training Program (NETP) will train a new generation of scientists with both hard engineering skills and a solid understanding of the underlying biology. Trainees of this program will create the next generation of bioelectronic implants, in collaboration with clinicians, basic scientists, and industry. By exposing students to clinical practice, NETP trainees will be well prepared to solve the challenges facing neurotechnology and bioelectronics.